Investigating the role of protein quality control in osmotic stress adaptation

PROJECT SUMMARY
Virtually all organisms experience osmotic imbalances from their environment, which can cause rapid changes
in cell volume. Hypertonic exposure causes cell shrinkage and is thought to induce protein misfolding and
aggregation in vivo. Despite these proteotoxic effects, the main paradigm for osmotic stress adaptation is still
focused on osmolyte production and cell volume recovery. Little is known about the mechanisms that maintain
proteome integrity during osmotic stress, and no studies have investigated the identity of proteins
compromised by hypertonicity. Therefore, the goal of this project is to characterize the protein quality
consequences (Aim 1) and responses (Aim 2) to hypertonic exposure. The research strategy leverages
targeted and systems-level technologies, including aggregation assays, genome-editing, and mass
spectrometry, to examine the molecular and systems-level aspects of proteostasis during osmotic stress. In
Aim 1, the applicant Kathy Le will test the hypothesis that subsets of the proteome, including nascent proteins
and peroxisomal proteins, are particularly susceptible to osmotically induced aggregation. Using targeted
biochemical approaches, Kathy will quantify aggregation of pulse-labeled nascent chains and the effects of
translation inhibition. She will also receive individualized training in mass spectrometry techniques to profile
aggregation propensity across the yeast proteome, including peroxisomal proteins. In Aim 2, Kathy will test the
hypothesis that chaperone-mediated refolding and proteasomal degradation contribute to osmotic stress
resistance by acting on different sets of misfolded substrates. Leveraging yeast genetics, Kathy will measure
the individual stress tolerance contributions of the chaperone system and the ubiquitin-proteasome system.
She will also use a combination of biochemical aggregate assays and proteomics to analyze the protein
substrate pools of each system and determine the extent of their overlap. The proposed project and training
plan is tailored to enable Kathy to gain new experimental skills and concepts in proteostasis, a diverse
research field led by multiple experts at Stanford. Dr. Brandman (sponsor) has extensive experience studying
the heat shock response and the adaptability of chaperones using cell biological tools and CRISPR libraries in
yeast. Dr. Kopito (co-sponsor) is a renowned expert in studying mammalian ER-associated degradation
(ERAD) and misfolded protein substrate selection, offering a complementary perspective. In summary, the
strong mentoring and training opportunities at Stanford will fully prepare Kathy for an independent research
career. The proposed Aims will challenge the current paradigm of osmotic stress adaptation by investigating
the protein quality aspects of hypertonicity. Understanding of the mechanisms that drive protein aggregate
formation, refolding, and degradation in a variety of physiological contexts is needed to elucidate general
principles for protein quality control and therapeutic strategies for protein-misfolding diseases.

Public health relevance
PROJECT NARRATIVE Hypertonic exposure causes cell shrinkage and is thought to induce in vivo protein misfolding and aggregation, which are hallmarks for aging, cancer, and neurodegeneration. However, no studies have determined which endogenous proteins are compromised by hypertonicity, and little is known about the mechanisms that maintain proteome integrity during osmotic stress. The experiments proposed here will characterize the protein quality consequences and responses to hypertonic exposure, identifying determining factors for protein aggregation, refolding, and degradation that may inspire therapeutic strategies for protein-misfolding diseases.